On-Site Detection of Benzo(a)pyrene in Water and Soil

Project Summary Benzo(a)pyrene (BaP) is universally present in polycyclic aromatic hydrocarbon mixtures and is listed as a Group 1 carcinogen by the International Agency for Research on Cancer. Among the current 1317 Superfund sites on the National Priorities List as of February 2017, and BaP has been found at 524 sites. There is an urgent need for development of a novel onsite assay for rapid, sensitive, reliable and cost-effective identification and quantification of BaP in soil and water at Superfund sites. In this project, Ocean NanoTech proposes to develop and commercialize a quantum dot-based quantitative FRET (QFRET) immunoassay for fast on-site detection of BaP. Compared to the existing technologies, the proposed platform assay will possess the following advanced attributes: high sensitivity, high specificity, fieldability, fast detection (minutes vs days for lab test), ease of operation (wash-free, mix-and-read), and low operation cost. An anticipated product will be an evaluation kit including reagents, glass or plastic tubes, and a compact photoluminescent reader. The goal of Phase I is to demonstrate the feasibility of this novel assay platform. In Phase II, one of the aims will be to design a compact and inexpensive reader for on- site detection.

Public health relevance
Project Narrative (relevance to public health): The proposed quantum dot-based quantitative immunoassay for onsite detection of benzo(a)pyrene will promote safety management practices at Superfund sites, which reduces the public exposure to benzo(a)pyrene and other polycyclic aromatic hydrocarbons, one class of the most toxic pollutants associated with cancer and other diseases.